RURAL AT RISK WOMEN DRINKERS--SERVICES &OUTCOMES

APPLICANT'S ABSTRACT: This application proposes to study services and outcomes for rural women with at-risk alcohol use. In general, we know little about the relationships between alcohol use disorders and treatment services in rural women, mostly because few studies of substance use or mental health disorders have focused on rural populations. We will conduct secondary data analyses and review of medical records already collected in The Rural Alcohol Study, a four-wave longitudinal survey funded by NIAAA between 1995 and 1998. We will study barriers to services, use of alcohol, mental health, or primary care services, and outcomes in rural women from a random sample of 733 male and female at-risk drinkers (female participants n=239 or 32%) in the rural and urban South. Our proposed study h@is four specific aims: (1) To identify rural/urban differences in predictors of service use in female at-risk drinkers; (2) To determine rural/urban differences in the type and content of service use over two years in female at-risk drinkers, including use of primary care for alcohol, mental health, and physical problems; use of specialty mental health services; and use of specialty alcohol treatment services; (3) To determine rural/urban differences in outcomes over a two-year period in female at-risk drinkers, including drinking outcomes; mental health outcomes; health status; victimization; and family and social relationships; and (4) To determine whether the effects of rural residence are similar for both women and men and the relative strength of rural residence compared to the relative strength of gender in predicting service use and outcomes. To accomplish the study's specific aims, we will abstract medical records already obtained for information on alcohol, mental health, and medical/primary care services use in multiple sectors of health care; conduct extensive secondary data analyses with the four-wave interview data, with and without the medical records data; and publish at least four papers and make at least four presentations at national meetings related to our specific aims.